P30 Core Grant for Vision Research

Project summary- Administrative core
This proposal describes the Administrative core for the Massachusetts Eye and Ear Infirmary (MEEI)
P30 Center Core Grant for Vision Research. The purpose of the Administrative core is to 1) ensure
equitable usage of the service cores; 2) manage the P30 budget and resources; 3) integrate core
resources and coordinate activity among the core services; and 4) evaluate the core services and
revise as user needs evolve. The administrative core is directed by the PI, Dr. Wiggs, with assistance
from the resource core directors (Drs. Pierce, Sobrin, and Bujakowska), an Internal Advisory
committee that includes the resource core directors and other senior staff, and an External Advisory
Committee that includes the resource core directors as well as the PIs of the other two HMS P30s
(Drs. Livingstone and Argueso).